Therapeutic Editing of Rod Glycolysis Rescues Retinal Degeneration

PROJECT SUMMARY
Retinitis pigmentosa (RP) is the most common inherited retinal dystrophy, caused by more than 3100 mutations
in 80 genes that are primarily specific to rod photoreceptors. Following the major rod death phase, cone death
occurs regardless of the underlying gene mutations. However, there exists a knowledge gap in understanding
how aerobic glycolysis in cones impacts the delicate “metabolic coupling” between cones and retinal pigment
epithelium (RPE) in RP. In this proposal, we hypothesize that reprogramming rod and cone aerobic glycolysis
can promote cone survival in RP independent of the underlying rod-specific gene mutations. To test this
hypothesis, we propose the following specific aims. In Aim 1, we will determine whether enhanced aerobic
glycolysis in cone photoreceptors can promote their survival in a novel genetic mouse model. In Aim 2, we will
test the potential of gene therapy to slow photoreceptor degeneration by enhancing aerobic glycolysis in mouse
models of RP and characterizing the metabolic changes that occur. Lastly, in Aim 3, we will evaluate the safety
profile of the gene therapy described in Aim 2.

Public health relevance
PROJECT NARRATIVE Phosphodiesterase (PDE6)- related retinopathies blind nearly 72,000 individuals worldwide, and there is currently no treatment available to stop disease progression. CRISPR-mediated gene editing, is a challenging clinical treatment option due to its gene- and mutation-specific guide RNA (gRNA) targeting requirements and delivery. We propose to address this problem by developing an efficacious strategy to treat cone degenerations, identify and optimize the CRISPR delivery method best suited for these conditions, and finally, enable treatment in a manner that is not mutation specific.